BCCMA: Basic and Translational Mechanisms of Cancer Initiation of the Urothelium in Veterans Exposed to Carcinogens: Leveraging Artificial Neural Networks to Enhance Detection of Carcinoma in situ

PROJECT SUMMARY ABSTRACT
Herein, a group of collaborative merit review applications (CMA) aim to advance the precision
management of bladder cancer (BCa), especially focused on the early stage initiation of urothelium as
a model of dynamic epithelial changes in response to smoking and deployment-related carcinogens.
Malignancies are the second most common cause of death among Veterans and BCa is the fourth
most common cancer in the VA. Among tumor types, 70% of BCa is confined to the superficial part of
the bladder (Stages T1, Ta, and CIS), with the remainder invasive of the muscle or metastatic. If BCas
are identified at an earlier stage, nearly all of these tumors are treatable with a combination of surgery
and intracavitary therapy. Yet, there are currently no validated or recommended screening procedures
to identify asymptomatic BCas and there are no methods to identify at-risk patients at an earlier and
more curable stage. The proposed CMAs aim to address these limitations and to significantly disrupt
BCa prevention, detection, risk stratification and precision treatment by dissecting the genetic and
molecular foundations of early stage BCa. The projects include the following: CMA1 aims to determine
the genetic and immune-suppressive landscape of CIS to identify new therapeutics and
immunotherapies. CMA2 investigates the plasticity of the urothelium to determine how PPARγ can
direct epithelial differentiation as a possible modulator of CIS. CMA3 will examine the epigenetic basis
of urothelial differentiation and the role of LSD1-inhibitor, Methysticin, as a chemopreventative agent to
restore the epigenetic imbalance of the urothelium. Finally, CMA4 will develop artificial intelligence
algorithms for enhanced cystoscopy imaging technologies or BCa detection and risk stratification.
These CMAs are linked both intrinsically among each other and extrinsically with all contributors already
supported by VA R&D with Merit Awards focused on BCa to maximize synergy and ensure success.
Rationale: More than 80% of Veterans report a history of tobacco smoking with 90% of Veterans with
BCa self-reported smokers. Unlike lung, prostate or colorectal cancer, there are no screening protocols
recommended for Veterans at risk for BCa. There is no primary care recommendation for uniform
evaluation of blood in the urine, and no urinary tests have a high negative predictive value that can
replace cystoscopy. Almost all patients with BCa develop blood in the urine at some time, but there is
often delays in pursuing an evaluation by months to years that lead to tumor progression due to lack of
referrals to urologic surgery for evaluation. Once diagnosed, the urothelium is often challenging to follow
and up 20% of invasive tumors will progress to higher stage cancer. Treatment for early stage invasive
bladder cancer is dependent on BCG immunotherapy, but BCG is frequently unavailable and
underutilized for maintenance and 30% of BCas become BCG unresponsive. Therefore, the three major
challenges for improving survival for patients with BCa are 1) early detection of high-risk tumors 2)
identification of progression to higher stage cancer and 3) treatment resistance to BCG immunotherapy.
Our preliminary data suggest that the urothelium has plasticity in early stage BCa that, if understood at
the genetic, epigenetic and molecular level, could be treated and driven to a more indolent cancer.
Based on our preliminary studies and the gaps in diagnosis and treatment we hypothesize that the
urothelium can be influenced by the state of epithelial differentiation and driven towards a more stable
state if detected at early time point.

Public health relevance
PROJECT NARRATIVE Bladder cancer is the fourth most prevalent cancer among Veterans. Carcinoma in situ (CIS) of the bladder is a pre-invasive lesion caused by carcinogens in tobacco smoke, occupational exposures to hazardous chemicals, and chemical/biologic warfare. CIS has a high rate of recurrence and progression to invasion and metastasis. CIS is a major diagnostic challenge and up to 40% of CIS are missed by standard cystoscopy. Current approved cystoscopy technologies have significant shortcomings, particularly high false positive rates. We aim to leverage artificial intelligence to augment enhanced cystoscopy imaging technologies to improve real-time cystoscopic detection and characterization of CIS. We propose three specific aims: 1) to develop an annotated multimodal cystoscopy imaging dataset for CIS of the bladder; 2) to develop and train deep learning algorithms for detection of CIS of the bladder; and 3) to augment detection of CIS of the bladder using deep learning algorithms in clinical settings.